DNA aptamers as tools for toxin delivery to glioblastoma

Title: DNA aptamers as tools for toxin delivery to glioblastoma
Despite recent advances in understanding the pathophysiology of glioblastoma (GBM), translation into improved
clinical outcomes is absent. With a 5-year survival rate of less than 5%, nearly every patient with GBM will
experience recurrence and succumb to the disease. Therapeutic efficacy is hindered by obstacles including the
highly selective blood brain barrier (BBB), and inherent tumor characteristics such as high intratumor
heterogeneity, which enables therapeutic resistance and recurrence. Aptamers are short, synthetic, single
strands of DNA or RNA. Folding into three-dimensional shapes inherent to oligonucleotides, aptamers act as
nucleic acid antibodies, binding ligands with equilibrium dissociation constants in the nanomolar region,
comparable to antibodies. Aptamers are also ~6-fold smaller than antibodies and some have the potential to
cross the BBB. Aptamers are identified through Systematic Evolution of Ligands by Exponential Enrichment
(SELEX) and preliminary experiments suggest that for aptamers to be developed as successful aptamer drug
conjugates (ApDCs), training of drug conjugates to properly localize and release the free drug must be included
in the SELEX process itself. Thus, this study seeks to optimize approaches to identify DNA aptamers that can
be used as GBM-specific ApDCs. Overall question: Can we develop new drug conjugates that deliver therapy
to GBM tumors otherwise resistant to treatment due to the blood-brain-barrier and intratumoral heterogeneity?
Central Hypothesis: DNA aptamer-drug conjugates can be selected from a vast random library for their ability
to home to human GBM patient-derived xenograft (PDX) tumors in mice. Aim 1 will identify GBM-specific MMAE-
conjugated DNA aptamers in PDX models. Aim 2 will select ApDCs for intracellular MMAE toxin delivery. Long
term goal: Develop a diverse library of therapeutically effective anti-GBM ApDCs from which personalized
ApDCs cocktails could be selected to treat GBM patients. Completion of this study will impact the fields of both
aptamer technology development and neuro-oncology, while potentially identifying novel therapeutic modalities.
Additionally, the research aims of this proposal, coupled with my education plan, provide a unique training
opportunity for me to translate my preliminary basic science data into a potential GBM therapy. Not only will the
proposed fellowship train me to become an expert in the field of ApDCs, but the project and training environment
will also take me one step closer to becoming an effective physician scientist.

Public health relevance
Project Narrative: Glioblastoma is an aggressive type of brain tumor that is very difficult to treat. We propose to use DNA aptamers to find rare, folded DNAs that can deliver highly toxic drugs to glioblastomas. In aptamer technology, collections of trillions of random DNA strands are coupled to toxins, and only the rare strands capable of reaching glioblastomas are identified and copied.